Mechanosensitive determinants of podocyte physiology

PROJECT SUMMARY
Drug nephrotoxicity is often conflated with tubular injury; however, many nephrotoxic agents target the
glomerulus leading to proteinuric kidney disease. Mechanisms of drug-induced glomerular dysfunction are not
well understood. We have previously shown that altered cytoskeletal integrity of podocytes leads to changes in
their resilience making them vulnerable to nephrotoxic agents that impact the cytoskeleton. Using meta-
analyses to analyze reported renal adverse events of FDA-approved drugs, we identified a previously unknown
mechanism of protein kinase inhibitor toxicity that targets actin biophysics. In this project, we utilize this link
between regulatory kinase activity and the biomechanical resilience of podocytes to uncover the key signaling
landscape that impacts glomerular function. We use a combination of in vitro and in vivo models of cell
signaling to mechanistically link the clinically-observed glomerular adverse events with cellular and subcellular
characteristics in human podocytes. Using high-content image analytics, atomic force microscope elastography,
single-cell transcriptomics and phosphoproteomics, we will identify molecular, morphological and biophysical
properties associated with protein kinase inhibitor induced impairment of podocyte cytoskeletal and focal
adhesion dynamics. Grounded with multiple sets of in vivo proteomic data from the transient puromycin
aminonucleoside nephropathy and spontaneously hypertensive rat models, we identified key kinome
signatures that are responsible for maintaining glomerular integrity. Integrating the in vitro and in vivo model
system results using network-based systems biology methods, we will identify potential drug interaction hubs
and binding domains that impact cytoskeletal resilience and test these predictions in vivo in three
complementary transgenic mouse models of experimental glomerular disease. This integrative study will have
an immediate impact on clinical standard of care by improving renal monitoring of patients and by identifying
potential risk factors of nephrotoxicity. Furthermore, our quantitative cellular screening platform could help
mitigate risks for future treatment regimens. Finally, our project will lead to a better understanding of glomerular
structural integrity, and it may enable identification of key kinases that are responsible for maintaining podocyte
cytoskeletal dynamics.

Public health relevance
PROJECT NARRATIVE Podocytes are structural cells that form a critical layer of the filtration barrier in the kidney glomerulus. Using cutting-edge molecular and imaging assays, we propose to study the biological components that are inhibited by oncological drugs, leading to kidney toxicity. Our results may help us improve the resilience of podocytes against toxic agents; translate into superior patient monitoring against harmful side effects of drugs; and design therapeutics that may help improve the health and function of podocytes.